Clinical and Translational Science Award

Our mission is to improve the health of our patients and communities both locally and nationally through innovations in clinical and translational research. Our strategic vision is to catalyze all phases of clinical and translational science (T0-T4), synergize with our partners and stakeholders, and integrate activities within our hub and across the national Clinical and Translational Science Award (CTSA) Program. To achieve this vision, we will build on our strong established track-record (e.g., in precision medicine), our plans to tackle important public-health challenges and to address critical barriers (e.g., innovation in use of electronic health records for research, clinical trial designs) as we embrace the CTSA Program priorities designated in PAR-18-940. Our vision is to transform the health and wellbeing of our communities in New York City, the nation and the world. To achieve this, we deploy our programs and resources to develop, demonstrate and disseminate innovations in clinical and translational science across the full translational spectrum. As a comprehensive CTSA, we offer a broad array of support for trainees, scholars and investigators across our entire hub which includes Columbia University, the Columbia University Irving Medical Center, the New York Psychiatric Institute, and New York Presbyterian Hospital. At the same time, we move flexibly and deeply to address critical scientific or institutional opportunities as well as major public health needs and gaps. We achieve success by approaching our goals at multiple levels: a) Ongoing strategic planning including an annual retreat to review operations and identify gaps, needs and opportunities; b) Monthly cross- cutting “Theme” meetings to enable collaborative problem-solving in addressing gaps and opportunities; c) An innovative Evaluation and Continuous Improvement strategy using participatory management to integrate evaluation into program planning and execution; and d) A highly successful, innovative interdisciplinary training and workforce development program built on a foundation of team science. Central to our efforts to improve health and wellbeing at personal, community and national levels is our emphasis on strategic collaboration and dissemination. Thus, we seek to continuously create and refine innovations for an integrated research- and user- friendly translational research environment at our hub by: Harnessing partnerships across our entire hub; Transforming collaborations with our local communities, the campus health system and across New York State; And by accelerating bidirectional dissemination of innovative practices and learnings through collaborations with the CTSA Program network and beyond.

Public health relevance
The Clinical and Translational Science Award (CTSA) allows Columbia University to support novel programs whose goal is to speed the transition from scientific discoveries made in the laboratory toward new therapies. Building on our strong established track-record, we will tackle important challenges and critical barriers to research. We will facilitate the training of scholars in translational science who are knowledgeable about and available to focus on translational science later in their careers.